Local and global regulation of bacterial growth

Bacteria impact human health in myriad ways, including as infectious agents and beneficial members of our
microbiota. As single-celled organisms, bacteria must be able to reproduce through successive rounds of cell
division to generate a population of cells that can cause infection or act as beneficial commensals. Moreover,
bacterial survival requires an ability to sense and respond to changes in their environment, including stresses
like antibiotics. Our proposed work centers on these two fundamental aspects of bacterial life – replication and
adaptation – with a focus on the role of the cell envelope in these processes. We leverage the dimorphic
alphaproteobacterium Caulobacter crescentus for this research. In our first research area, we will continue to
build on our recent work delineating a pathway the links chromosome segregation to the activation of
peptidoglycan cell wall synthesis that drives constriction during division. We will use a diverse array of
approaches including genetics, biochemistry, and advanced imaging to establish the mechanisms that allow
Caulobacter to ensure genome integrity throughout the process of cell division. In the second research area,
we will build on a framework we recently established to understand the composition and function of envelope
components known as osmoregulated periplasmic glucans (OPGs) in ensuring envelope integrity and
promoting morphogenesis and survival. OPGs are essential in Caulobacter, and their loss has both direct
effects on morphology and indirect effects through activation of the CenKR two-component system that
regulates envelope homeostasis. We will leverage genetics, biochemistry, advanced imaging, and
transcriptomics to understand how OPGs are metabolized, how they promote envelope integrity and
morphogenesis, and how they integrate with the CenKR two-component system. Collectively our work will
advance our understanding of key aspects of bacterial physiology and replication, and will promote our ability
to combat antibiotic resistance through identification of new therapeutic targets.

Public health relevance
To impact human health, bacteria must be able both to replicate and to adapt to changing environmental conditions or stresses like antibiotics. Our research aims to understand how bacteria replicate through the process of cell division and how they maintain their cell envelope during stress. Our findings will inform development of novel antibiotics and our understanding of antibiotic resistance, helping us to combat bacterial infectious disease.